Ohio Valley Regional Coordinating Center for NINDS Stroke Trial Network

PROJECT SUMMARY
The objectives of the NIH Stroke NET are to harness multidisciplinary stroke expertise to collaboratively and efficiently conduct NINDS-sponsored stroke trials in all domains (acute, prevention, recovery). The Ohio Valley (formerly Cincinnati) Regional Coordinating Center is composed of 33 hospitals served by the University of Cincinnati (UC) stroke team network, and one highly active satellite hospital, The Ohio State University with 6 enrolling hospitals. Our goals are to (1) efficiently initiate trials, recruit and retain participants, and optimize data quality; (2) actively contribute to the overall success of NIH Stroke NET; and (3) Successfully train the next generation of stroke researchers. We will achieve this by continuing to bring an established research infrastructure, a large and diverse patient population, experienced leadership, a rich training program, and a supportive administration. We have been successful as an RCC by all metrics in the prior grant cycle, including rapid trial initiation, high trial recruitment, high data quality, and consistent Stroke NET participation. Our sites have shown their commitment to NIH Stroke Net’s training mission by maintaining a robust training and education program. Our department has shown its support by providing additional funds to complete the RCC trainee’s salary and benefits and support effort of our Research Manager. We are committed to continued partnership with NIH Stroke NET to advance stroke care and research opportunities for our patients.

Public health relevance
PROJECT NARRATIVE Despite advances in stroke prevention and treatment, stroke continues is a public health priority as a leading cause of death and disability worldwide. Multicenter clinical trials are needed to test new discoveries that may reduce this burden in the treatment, prevention, and recovery arenas. The Ohio Valley RCC proposes continued partnership with the NIH Stroke NET to improve clinical trial efficiency, success, and quality, and thereby advance stroke care.